APOE4 dependent regulation of CSF Complement Pathway Activation in the development of Alzheimer's Disease

Dementia is a common disorder that increases in frequency in the elderly. Dementia is a
progressive loss of thinking and memory skills that eventually results in an inability to care for
oneself and to live independently. The most common cause of dementia in older Americans is
Alzheimer’s Disease, which develops as a result of multiple lifestyle/environmental factors and
inherited or familial causes. Many familial traits (such as the risk of developing Alzheimer’s
disease) are inherited genetically, through gene variants (sequences of a chemical code called
DNA). The most common genetic variant that increases the risk of Alzheimer’s disease is called
APOE4. Although we have known for over 25 years that inheriting an APOE4 genetic variant (also
called an allele) increases Alzheimer’s disease risk, it is unclear how and why APOE4 increases
this risk. Recent data has raised the possibility that APOE4 may act by increasing the activation
of the complement pathway, a set of proteins that are used by immune cells to kill and eat bacteria,
and that also play a role in “killing” and “eating” connections between nerve cells in the brain,
known as synapses. In this project, we will examine whether people that carry the APOE4 allele
(either 1 or 2 copies of this allele) have increased evidence of complement pathway activation in
the fluid that bathes their brain and spinal cord, known as the cerebrospinal fluid (CSF) across
the full adult lifespan. We have begun to assemble a set of CSF samples from our own studies
as well as biobanks in the US and Europe. To date we have collected or received approval to
use CSF samples from 400 individuals. This administrative supplement will allow us to recruit
additional subjects between the ages of 18-39 to complete the set of CSF samples needed for
this analysis. These samples will be analyzed using an advanced method that can measure the
levels of a large percentage of all proteins present in human CSF, and which can precisely
measure the levels of proteins in the complement pathway. Overall, this work will help us
understand how and why APOE4 changes the function of the brain, and how and why it
contributes to AD risk. This work is an early step towards identifying proteins or pathways that
could be targeted by drugs to prevent Alzheimer’s disease in people that carry an APOE4 allele
before the onset of any clinical symptoms.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is the most common cause of dementia in older adults, and the most common inherited genetic risk factor of AD is the APOE4 allele of the apolipoprotein E gene. Despite extensive research, it is unclear how APOE4 increases the AD risk. In this administrative supplement project, we will enhance the statistical power of our R01 project without altering its main goal, and evaluate the role of APOE4-related alterations in the complement pathway using cerebrospinal fluid (CSF) collected from subjects across the entire adult lifespan (ages 18-80+), thus we will determine early potential markers of AD long before the onset of this debilitating disease.